Best Practices for the Measurement and Analysis of Cognitive Data in the International Health and Retirement Study (HRS) Family and its Harmonized Cognitive Assessment Protocol (HCAP)

Alzheimer's disease and related dementias (AD/ADRD) present significant global public health challenges,
with a projected majority of future cases occurring in low- and middle-income countries. Cross-national
research is essential to understand the diverse factors influencing cognitive aging and to develop effective
interventions. The International Health and Retirement Study (HRS) Family and its Harmonized Cognitive
Assessment Protocol (HCAP) offer unique datasets across diverse populations providing unparalleled
opportunities for such research. However, the complexity of these datasets and the advanced
methodological skills required for their analysis are barriers to widespread utilization. We propose a
research education program titled Best Practices for the Measurement and Analysis of Cognitive Data in the
International Health and Retirement Study (HRS) Family and its Harmonized Cognitive Assessment
Protocol (HCAP). The program consists of two complementary short courses: Course One: Designing and
Leading Cross-National Studies with HRS and HCAP Cognitive Data introduces participants to the cognitive
data available in the International HRS and HCAP studies, the concept of harmonization, and best practices
for designing substantive research questions and analyses involving cross-national comparisons. It is
tailored for principal investigators, lab leaders, and researchers planning studies utilizing international HRS
or HCAP cognitive data. Course Two: Applied Measurement Modeling in Cross-National Cognitive Aging
Research provides advanced instruction in statistical methods, including item response theory and structural
equation modeling, with hands-on computing practice using the international HRS and HCAP data. It is
intended for researchers who wish to develop practical data analysis skills necessary for conducting
advanced psychometric analyses required for statistical harmonization. Our specific aims are to develop
and deliver the two-part summer short course to equip researchers with the necessary skills to conduct
rigorous cross-national AD/ADRD research using the International HRS and HCAP data (Aim 1); expand the
reach and impact of the training program through online resources and outreach activities. Course materials
and lectures publicly will be available on-demand, offering condensed versions as pre-conference
workshops, and providing "flipped" classroom options for remote participants (Aim 2); and, develop a
community of practice among researchers by facilitating communication and collaboration through online
forums, networking opportunities, and continuous engagement (Aim 3). By providing targeted training and
resources, our program will empower researchers to utilize the International HRS and HCAP data effectively
to enhance the quality and impact of cross-national cognitive aging research. This initiative will contribute to
significant scientific advancements in understanding the cognitive health of older adults worldwide and
support efforts to mitigate the global impact of AD/ADRD.

Public health relevance
By 2050, 75% of global Alzheimer’s disease and related dementia (AD/ADRD) cases are projected to occur in low- and middle-income countries, highlighting the need to leverage cross-national research to gain new insights into the causes and consequences of AD/ADRD across diverse populations and settings that would not be clear from studies conducted in high-income countries or in single populations alone. The International Health and Retirement Study (HRS) family and its Harmonized Cognitive Assessment Protocol (HCAP) provide a “cross-national laboratory” with which to investigate variation in cognitive aging and AD/ADRD outcomes across a diversity of social, economic, geographical, linguistic, and cultural contexts. The proposed R25 Research Education Program will increase utilization of the International HRS and HCAP data for cross-national AD/ADRD research and improve the quality of such research through providing hands-on instruction in the best practices for the measurement and analysis of harmonized cognition data from around the world.